Regulation of sphingolipid biosynthesis and motor neuron disease

Project Summary
Amyotrophic lateral sclerosis (ALS) is a fatal, degenerative disease of the upper and lower motor neurons. ALS
is a clinically and biologically heterogeneous disease and includes sporadic and genetic forms. Several cellular
mechanisms have been linked to neurodegeneration in ALS, but few metabolic causes of the disease have been
comprehensively studied. Disruptions in lipid metabolism pathways have recently been linked to
neurodegeneration in ALS, making it an emerging area of inquiry. We and others have recently discovered and
reported a distinct class of mutations in the enzyme serine palmitoyltransferase (SPT) that cause a monogenic
form of juvenile ALS. Sphingolipids are a subgroup of lipids that serve as components of cell membranes and
organelles, as well as potent signaling molecules. SPT catalyzes the first step in sphingolipid biosynthesis and
its activity is closely regulated to meet cellular demands but avoid accumulation of excess sphingolipids. We
have shown that the SPT-related ALS mutations are gain-of-function variants that disrupt the ORMDL/ceramide-
mediated inhibition of SPT and thus result in unrestrained SPT activity. However, how excess sphingolipid
synthesis causes motor neuron degeneration is not clearly delineated. We have established cellular models of
this disease in patient fibroblasts as well as iPSCs. We have also obtained knock-in mouse models of SPT-
related ALS. Our preliminary studies show that our models of the disease recapitulate SPT overactivity. They
also show that the SPT-related mutations result in mitochondrial bioenergetics dysfunction and morphological
abnormalities in human cell models of the disease. In addition, we have shown increased ceramide content in
mitochondria of SPT-related ALS cell models. Together, these findings prompted us to hypothesize that increased
SPT activity results in increased mitochondrial ceramide content and mitochondrial dysfunction, which in turn
leads to neurodegeneration. In this application, we propose to test this hypothesis. In specific aim 1, we will
evaluate mitochondrial bioenergetics, morphology, mitophagy flux, and mitochondrial cell death pathways in
SPT-related ALS patient cells. We will also measure the sphingolipid content of isolated mitochondria in our cell
models. In specific aim 2, we will evaluate mitochondrial dysfunction in mouse tissues and primary cell cultures
of the mouse nervous system. In addition, we will use co-culture systems to assess if myelinating glia contribute
to motor neuron degeneration in SPT-related ALS. In specific aim 3, we will evaluate the efficacy of anti-sense
oligonucleotides that reduce SPT activity in restoring normal mitochondrial function and motor neuron
dysfunction in human cells and mouse models of the disease. Together, the studies proposed in this application
will advance our understanding of underlying metabolic pathomechanisms of neurodegeneration caused by
dysregulation of sphingolipid biosynthesis and enable future therapeutic strategies that target this pathway.

Public health relevance
Project Narrative Sphingolipids are a class of lipids that play key roles in biological functions in all eukaryotes. We have recently identified distinct mutations in the enzyme that catalyzes the first step in synthesis of sphingolipids, serine palmitoyltransferase (SPT), that lead to amyotrophic lateral sclerosis and motor neuron degeneration in patients. Here, we will study how these mutations result in degeneration of neurons in the laboratory and investigate whether reducing the activity of SPT would be a feasible therapeutic strategy.